Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The long-term goal of the Kansas Institute for Precision Medicine (KIPM) is to develop a multi-disciplinary
research environment focused on precision medicine to advance healthcare through innovative discoveries. This
Phase 2 COBRE program will provide unique training for biomedical researchers focused on the theme of
precision medicine by providing the appropriate financial support, dedicated mentoring teams, and a strong
research infrastructure, which includes an active patient and community engagement program. The
responsibilities of the Administrative Core will include actively monitoring an extensive mentoring program for
Research Project Leaders (RPLs), overseeing a robust research Pilot Projects Program (PPP), arranging for
reviews by a newly formed Advisory Committee (AC), and conducting a community engagement program
focused on advancing inclusivity. The Administrative Core will also oversee the COBRE Research Cores, i.e.,
the Biomedical Engineering (BME), Biobanking and Biomarker Validation (BBV), and Quantitative ‘OmiCs’
(QOC) Cores. The KIPM Phase 2 COBRE will continue to be led by Andrew K. Godwin, PhD (Director), Steven
A. Soper, PhD (Associate Director), and Alan S.L. Yu, MB, B. Chir (Director of Mentoring and Career
Development) and will position promising young scientists to effectively compete for independent research
funding. The Administrative Core will play an important role in the COBRE program by setting the overall scientific
direction of KIPM’s activities, coordinating and integrating all KIPM’s functions, establishing areas of research
emphasis, and promoting internal and external collaborative interactions. This Core will be responsible for the
overall management of the administrative, fiscal, and scientific aspects of KIPM. Dr. Godwin will have primary
administrative oversight of the COBRE through the Administrative Core, but all KIPM activities will be managed
and evaluated jointly by the three principal investigators, who are seasoned leaders of large NIH projects. The
specific aims of the Administrative Core are to: 1) Establish the overall scientific direction of the KIPM COBRE;
2) implement a scientific and career development plan for RPLs; 3) administer and evaluate a research PPP for
Pilot Project Leaders; 4) convene AC meetings to review the KIPM (goals and progress); and 5) implement
training for KIPM faculty to embed community insight. These activities will be assisted by Ms. Jessica Leib (KIPM
COBRE administrator), who will be responsible for day-to-day administrative oversight of the COBRE and Ms.
Cassaundra Shipman (Grant Administrator), who will oversee the finances of the entire program. Both
administrators will work to gather and organize information quarterly related to the Research Performance
Progress Reports, including the progress of RPLs and their metrics. Overall, the proposed KIPM COBRE
Administrative Core will promote and strengthen interactions between the COBRE and the parent institution by
interfacing its activities with other programs, centers, and institutes at KUMC, and by integrating the biomedical
research cores with existing institutional shared resource centers to expand their impact.